Mathematical and Statistical Modeling of Mycobacterial Disease Control

DESCRIPTION (provided by Candidate): CANDIDATE: Dr. Rebecca Smith DVM MS, a veterinary epidemiologist, is currently enrolled in a Ph.D. program in the field of Clinical Biomedical Sciences at Cornell University College of Veterinary Medicine. Her work has been recognized to be unique and ground-breaking in linking disease modeling, statistics, and veterinary medicine. ENVIRONMENT: Dr. Smith's mentor, Dr. Yrjo Grohn is a highly respected veterinary epidemiologist, chair of Cornell University's Department of Population Medicine and Diagnostic Sciences. Dr. Grohn has expertise in disease modeling and statistical analysis of disease, and has mentored many graduate students, postdoctoral fellows, and visiting scholars in these fields. Dr. Smith will also be working with and mentored by a multi- disciplinary executive committee, including Dr. Robert Strawderman (Professor of Biological Statistics and Computational Biology), Dr. Loren Tauer (Chair of the Department of Applied Economics and Management), and Dr. David Russell (Chair of the Department of Microbiology and Immunology). TRAINING PLAN: The K01 award will support Dr. Smith's post-doctoral training and subsequent work as a Research Assistant. During this time, she will develop new mathematical and statistical models for mycobacterial diseases and transition into independence as a researcher. PROPOSAL: Dr. Smith will apply techniques developed for mathematical and statistical models of Mycobacterium avium subsp. paratuberculosis to three other mycobacterial diseases. A model for M. bovis spread within herds will be designed and analyzed to inform US eradication protocol. An existing model for M. tuberculosis will be used to economically and socially optimize control strategies, and will be used as the basis for a reverse jump Markov Chain Monte Carlo (rjMCMC) model that will be able to estimate vaccine and control program efficacy from field trials. A model will be designed and analyzed for M. leprae infection and parameterized using rjMCMC techniques; the finished model will be used to optimize control strategies. These models will reveal new areas of possible research at the intersection between human and animal health. PUBLIC HEALTH RELEVANCE (provided by Candidate): This study will develop methods to determine the efficacy of mycobacterial disease control programs, focusing on tuberculosis in humans and cattle and on leprosy in humans. Optimal control methods will be determined using the new techniques developed, improving public health strategies for these globally important diseases.

Public health relevance
Project Narrative This study will develop methods to determine the efficacy of mycobacterial disease control programs, focusing on tuberculosis in humans and cattle and on leprosy in humans. Optimal control methods will be determined using the new techniques developed, improving public health strategies for these globally important diseases.